Core C

Radiation and Imaging Core – Project Summary/Abstract
Translational research into the biology of cancer therapy side effects relies heavily on complex in vivo research
models that require specific expertise for their design and development, implementation, and
troubleshooting. The mission of the Radiation and Imaging Core (Core C) at the University of Arkansas
for Medical Sciences (UAMS) is to facilitate the development and use of imaging and experimental radiation in
pre-clinical models by investigators in the Center for Studies of Host Response to Cancer Therapy and other
users on campus and in surrounding institutions. During Phases 1 and 2 of the Center, Core C has
provided its services through 2 institutional core facilities: the UAMS Ultrasound Imaging Core and the
Winthrop P. Rockefeller Cancer Institute Radiation Biology Shared Resource, both of which operate on a fee-
for-service basis. In doing so, Core C has built a strong infrastructure for radiation research and high-
resolution ultrasound and magnetic resonance imaging of small animals. During Phase 3, Core C will
continue to provide these services to investigators at UAMS and surrounding institutions. The core will
perform high-resolution imaging of small research animals (Specific Aim 1); provide high-quality radiation
services in a wide range of research models (Specific Aim 2); provide mentoring, training, consultation, and
technical assistance within the core’s areas of expertise (Specific Aim 3); and become a self-sustaining
research core facility (Specific Aim 4). Core personnel confirm that the necessary maintenance, calibration,
and radiation dosimetry are performed to guarantee high-quality services. Core services are advertised with
poster and oral presentations at a range of departmental and institution-wide meetings and retreats, regional
and national NIGMS IDeA conferences, and other local and national research symposia. In Phase 3, we will
focus on increasing our visibility in the states surrounding Arkansas to increase the user base. Regular
surveys among core users will identify additional services that may be required, and with COBRE and
institutional support, such services will be developed. UAMS continues to expand its externally funded
research portfolio, with cancer research as one of the areas of emphasis, requiring state-of-the-art small animal
radiation and imaging services. In Phase 3, Core C will continue to provide critical research infrastructure and
training to investigators in the Center for Studies of Host Response to Cancer Therapy and other research
laboratories at UAMS and serve investigators from other institutions in Arkansas and surrounding states.